Head-neck RF coil with local field control for comprehensive high-resolution 7T neuro MRI exams

Project Summary/Abstract
Many diseases of the central nervous system (CNS: brain and spine) involve not only the neocortex but also
lower regions such as the cerebellum, brainstem, and cervical spine as well as vessels and nerves in the skull
base and neck. Diagnosis and tracking with MRI exams therefore requires full head-neck coverage, for
example in multiple sclerosis for visualizing demylinating lesions spanning from brain down to c-spine as well
as for surgical planning involving tumors in the skull face or face. For depicting subtle lesions and small
structures such as nerves and vessels, ultra-high field (7 Tesla) MRI provides superior image resolution and
enhanced soft tissue contrast as compared to conventional 3T imaging. Unfortunately, comprehensive
neurological exams covering the head and neck are not possible at present day due to the limited anatomical
coverage of standard radiofrequency (RF) head coils as well as artifacts arising from RF and magnetostatic
(B0) fields with the body. To overcome these limitations, this BPI project will forge a partnership between a
leading academic imaging center and the world’s preeminent UHF MRI vendor. Together, we will create a
head-neck imaging system that enables, for the first time, comprehensive neuro exams at 7T. To achieve this,
we design and build a 16-ch Tx/64-ch Rx coil with field coverage extending down to C6 that fits 95% of the
patient population comfortably and is optimized to balance Tx, Rx, and B0 shimming requirements. We apply
the state-of-the-art Siemens pTx framework to design “universal” RF pulses that robust excitation, inversion,
and refocusing over the whole head and neck. Moreover, we design an optimized B0 shim array to efficiently
null spatiotemporal DB0 fields over the head and neck, bringing them down to typical 3T levels. To track motion
and temporal B0 fluctuations in real-time, we use ~200 ms accelerated volumetric navigators (vNAVs) us to
stabilize the B0 field using real-time shim updating.

Public health relevance
Project Narrative Many diseases of the central nervous system (CNS: brain and spine) involve not only the neocortex but also lower regions such as cerebellum, brainstem, and cervical spine as well as vessels and nerves in the skull base. Ultra-high field 7 Tesla MRI provides unmatched resolution and contrast for depicting pathology in neuro exams, but unfortunately, at present there is no 7T radiofrequency head neck coil available for imaging the entire head and neck to support such exams. In this project, we will overcome this limitation and expand the clinical utility of 7T MRI by developing a next-generation RF coil covering the whole head and neck. To optimize image quality, we will leverage local field control in the form of state-of-the-art parallel transmit (pTx) pulse design to ensure uniform image quality over the whole region, as well as local magnetic field control to mitigate image artifacts.